Cellular Determinants and Function Consequences of PP2A-B56 Degradation by HIV-1 Vif

PROJECT SUMMARY
The HIV-1 Vif protein is expressed late during infection and has a well-described function to ubiquitinate and
degrade proteins in the APOBEC3 family, thus neutralizing their antiviral activities. More recently, an additional
function of HIV-1 Vif was described by us and others to ubiquitinate and degrade protein phosphatase 2A
holoenzymes containing B56 family regulatory subunits (PP2A-B56). The conservation of Vif-mediated PP2A-
B56 degradation throughout globally circulating HIV-1 subtypes suggests that it is functionally important.
However, there remains a gap in understanding the mechanisms by which PP2A-B56 degradation confers a
fitness advantage to HIV-1. Furthermore, in contrast to APOBEC3 degradation, the host cellular determinants
required for Vif-mediated ubiquitination and degradation of PP2A-B56 are undefined.
In this project, we aim to address these gaps in understanding by defining the cellular determinants and functional
effects of PP2A-B56 degradation by HIV-1 Vif. In Aim 1, we will apply unbiased protein interaction technologies
to determine proteins interacting with PP2A-B56 while it is degraded by Vif. In Aim 2, we will carry out a genome-
wide CRISPR/Cas9 genetic screen to identify genes regulating APOBEC3 and PP2A-B56 degradation. In Aim
3, will test the impact of individual phosphorylation sites regulated by PP2A-B56 in HIV-1 replication in primary
CD4+ T cells. Successful completion of this project will advance understanding of the Vif-PP2A-B56 signaling
axis, potentially leading towards the development of novel classes of antiretroviral therapies that target late
processes of HIV-1 infection.

Public health relevance
PROJECT NARRATIVE HIV-1 encodes proteins that modify the host cell to create an environment that is hospitable for replication. This project aims to understand a specific interaction between an HIV-1 protein, Vif, and a human protein complex, PP2A-B56. By understanding how this interaction occurs and why this interaction is important for HIV-1 infection, we aim to identify critical weaknesses that can be targeted for drug development.